THE CONVERSION OF PHENYLALANINE TO TYROSINE

In sharp contrast to the rat liver enzyme, human liver phenylalanine hydroxylase is in an activated state and can only be modestly activated by its substrate or by phosphorylation. 4A-Carbinolamine dehydratase, a component of the phenylalanine hydroxylating system also functions as part of a system that controls the expression of hepatic genes.